Characteristics and impact of chronic pain and pain management in older adults

PROJECT SUMMARY/ABSTRACT
Chronic pain and addiction are highly prevalent and frequently co-occurring conditions that produce synergistic
effects on individuals, providers, and health-care systems. However, no studies to date have conducted a
comprehensive evaluation of the co-occurrence of chronic pain and substance use among older adults (age
≥65). Focusing on older adults is critical given that this population is more susceptible to deleterious pain- and
substance use-related effects, has higher rates of multimorbidity and polypharmacy, and experiences age-
related changes in pharmacokinetics and pharmacodynamics. Therefore, research evaluating the prevalence
and impact of co-occurring chronic pain and substance use among this population is sorely needed.
In the parent R01 (AG064947), the research team is conducting a longitudinal population-based study of
chronic pain in older adults. We recruited a nationally representative sample of older adults (N=2038) from
NORC at the University of Chicago’s internally developed AmeriSpeak® Panel. Participants have already been
invited to complete two waves of data collection. In this administrative supplement, we will leverage the
infrastructure of the parent R01 to include a comprehensive assessment of co-occurring chronic pain and
substance use in older adults during Wave 3 of data collection. Specifically, we will add measures to assess
quantity/frequency of opioid and nonopioid (i.e., alcohol, cannabis, nicotine) substance use and the
presence/severity of problematic patterns of substance use. This approach will allow us to determine the
prevalence and characteristics of substance use among older adults with versus without chronic pain. In
addition, we will examine the effects of chronic pain, problematic substance use, and their co-occurrence on
important patient-reported outcomes (i.e., physical and cognitive function and quality of life). Finally, we will
explore theoretically informed biopsychosocial moderators of the hypothesized effects of chronic pain status on
substance use. This project will be the first comprehensive study of chronic pain and substance use conducted
with a nationally representative sample of older adults. The information obtained from this study will provide a
critical scientific starting point to understand the prevalence and impact of co-occurring chronic pain and
substance use among older adults. Findings will inform future descriptive and intervention studies to address
co-occurring chronic pain and substance use and improve patient-reported outcomes in the growing and highly
vulnerable population of older adults with chronic pain.

Public health relevance
PROJECT NARRATIVE This administrative supplement leverages our ongoing population-based study of chronic pain in older adults (R01AG064947) to perform the first comprehensive evaluation of substance use among older adults with and without chronic pain. We will fill major gaps in knowledge by examining the prevalence of substance use (including problematic use) among older adults with and without chronic pain; the potential impact of co- occurring chronic pain and problematic substance use on extremely important patient-reported outcomes; and the determination of biopsychosocial factors that influence the effects of chronic pain status on substance use. Findings will inform future studies and the development of tailored intervention strategies to address substance use and improve outcomes among older adults with chronic pain.